Role of SLAMF7 in Racial Disparities in Myeloma

Project Summary
Our long-term goal is to improve the care and outcomes of all patients with multiple myeloma (MM), particularly
African American (AA) patients to reduce racial disparity. MM exhibits one of the most striking racial disparities
between AA and White persons. MM has a 2-3 fold higher incidence and occurs at much earlier age in AA
persons. We found that the outcomes of AA patients with translocation t(11;14) myeloma were inferior to White
patients even after adjusted for comorbidities, disease stage, the length of treatment, and the use of blood and
bone marrow transplantation, etc. The mechanism for this racial disparity is unclear. We recently found that MM
cells from AA patients had a higher expression of the signaling lymphocyte activation molecule family member
7 (SLAMF7) and were more sensitive to the inhibition by SLAMF7 antibody crosslinking. The objective of this
proposal is to determine the effects of elotuzumab (an FDA approved, humanized SLAMF7 monoclonal
antibody) in AA and White patients with t(11;14) MM and the mechanism underlying the differences in SLAMF7
expression between AA and White patients with t(11;14) MM. Our central hypothesis is that elotuzumab is
particularly effective in AA patients with t(11;14) MM because of the higher expression of SLAMF7. Additionally,
we hypothesized that A>G single nucleotide polymorphism (SNP) at -742 of SLAMF7 promoter affects Blimp-
1- mediated SLAMF7 gene transcription and results in the differences in SLAMF7 expression between AA
patients and White patients with t(11;14) MM. The rationale for the proposed study is that with greater
understanding of the effectiveness of elotuzumab in AA patients with t(11;14) MM and the impact of this SNP,
we will be able to develop a more effective treatment regimen and biomarkers to reduce racial disparities. We
have two specific aims. Aim 1 is to determine the clinical outcomes of AA patients with t(11;14) myeloma and
White patients with t(11;14) myeloma in response to elotuzumab-based treatment. A retrospective cohort study
incorporating patient characteristics and social economic determinants will be performed to examine the
response and outcomes between AA patients with t(11;14) myeloma and White patients with t(11;14) myeloma
treated with elotuzumab-based regimens. STAR PCORnet datamart will be used and medical records from a
total of 257 patients with t(11;14) MM will be extracted and analyzed. Aim 2 is to determine the mechanism
underlying the differences in SLAMF7 expression between AA patients with t(11;14) MM and White patients
with t(11;14) MM. Chromatin immunoprecipitation assay, pGL-3 luciferase reporter system, site directed
mutagenesis, and tetra primer-amplification refractory mutation system-PCR will be performed. Our research is
innovative, because it incorporates novel technology and represents a new and substantive departure and
significant advance from the status quo. Our study will not only fundamentally advance our knowledge of racial
disparitie, but also have a positive translational impact on the care and outcomes of patients with MM, a disease
that affects AA population disproportionally.

Public health relevance
Project Narrative The proposed research is relevant to public health. Our study focuses on understanding the mechanisms driving the racial disparities in patients with multiple myeloma. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of human disability.